Prefrontal circuits controlling heroin seeking

PROJECT SUMMARY
Opioid use disorder (OUD) can be conceptualized as a two-sided coin, with one side of the pathology
characterized by excessive motivational drive for opioids, and on the other side, a weakened ability to suppress
opioid-seeking impulses. As the seat of executive function, the prefrontal cortex plays an integral role in the
decision ‘to seek or not to seek’ opioids. We have identified two functionally opposing prefrontal subcircuits that
drive versus limit opioid seeking. The infralimbic (IL) prefrontal cortex projection to the lateral hypothalamus
(ILàLH) drives heroin seeking, whereas the IL projection to the nucleus accumbens shell (ILàNAshell) limits it.
We also discovered that these distinct IL ensembles encode heroin cue-learning, a process that contributes to
subsequent relapse triggered by heroin cues encountered in the environment. Relapse is an important metric of
OUD pathology, but our data suggest that heroin choice, the tendency to choose heroin reward over non-drug
reward, is a separate metric of OUD pathology that does not always respond to treatments aimed at reducing
relapse. Thus, we will employ a preclinical model of OUD that captures multiple metrics of OUD pathology,
including heroin choice and relapse. Furthermore, the downstream target of the IL driver includes LH orexin
neurons, which we hypothesize are a biomarker of OUD pathology, as current evidence suggests the number of
these neurons increases after repeated opioid exposure and this number positively correlates with heroin
motivation. Our preliminary data indicate that the ILàLH driver subcircuit is more responsive to orexin than the
ILàNAshell limiter subcircuit, posing the possibility that a positive feedback loop in the ILàLH driver subcircuit
is engaged to perpetuate opioid seeking. Importantly, orexin antagonists have been a major focus in the search
for new OUD medications, and this newly identified driver circuit could be a major mechanism through which
orexin drives opioid seeking. The goals of this proposal are to determine whether the recruitment of the IL driver
circuit is a hallmark of heroin-induced pathology, whether this IL subcircuit engages a positive feedback loop via
the orexin system to further exacerbate heroin seeking, and whether simultaneously targeting both IL subcircuits
to normalize IL output can be used to reverse this pathology. The discovery of distinct IL driver and limiter circuits
that control heroin seeking is highly significant because it points to novel interventions aimed at shifting the
balance between these circuits as potential anti-addiction treatment strategies. We will also identify how the
orexin system interacts with this circuitry and whether this may be another potential point of intervention. The
information gained from these experiments could have profound implications for OUD treatment by identifying
multiple ways to restore adaptive functionality in these prefrontal circuits and ameliorate OUD pathology, either
by reducing excessive motivational drive for opioids or by strengthening inhibitory control over impulses to seek
opioids, or both.

Public health relevance
PROJECT NARRATIVE We have discovered two distinct prefrontal cortex subcircuits that gate the decision to seek or not to seek opioids. This project will determine how neuronal activity in these ‘driver’ versus ‘limiter’ subcircuits encodes heroin-cue learning, with a focus on strategies that shift the balance of activity in these subcircuits to reduce heroin drive and limit heroin seeking. We will also investigate whether these prefrontal circuits are highjacked by the hypothalamic orexin system to perpetuate heroin seeking after repeated opioids.